Pragmatic Clinical Trial of Continuous Glucose Monitoring-based Interventions for Safe Insulin Prescribing in High-Risk Older Patients with Type 2 Diabetes

Abstract
Hypoglycemia is a common and preventable complication of insulin treatment in type 2 diabetes (T2D)
that increases dramatically with age. In older adults (age ≥ 75), hypoglycemia accounts for 20% of all
Emergency Department admissions for adverse drug events (primarily due to insulin). Hypoglycemic
episodes in older adults are also associated with increased incidence of fall-related fractures,
cardiovascular events, cognitive decline and dementia, hospitalization, worse self-reported quality of
life, and mortality. For patients with T2D requiring insulin, optimal dosing requires monitoring glucose
levels and directional trends in the context of insulin type and dose, diet, physical activity, health status,
and symptoms. Severe hypoglycemia can occur at any time when the insulin regimen does not match
the corresponding patient needs. In older patients, frequent self-monitoring of blood glucose (SMBG)
using traditional fingerstick checks are often not physically possible (nor desirable). Moreover, many
older patients with long duration T2D have hypoglycemia unawareness (a potent risk factor for severe
hypoglycemia) and/or fear of hypoglycemia (with corresponding reluctance to inject full insulin dose).
The overarching goal of this R01 research proposal is to support safer management of insulin-requiring,
older adults (age ≥ 75) with T2D at high risk of severe hypoglycemia. We will test the hypothesis that in
these high-risk older adults with T2D, a group-based educational program that incorporates alarm-
enabled continuous glucose monitoring (CGM) will reduce the incidence of severe hypoglycemia as
defined by the American Diabetes Association as requiring active assistance from another person to
administer resuscitative measures. AIM 1: We will conduct a 3-arm randomized, pragmatic clinical trial
designed to test the efficacy of two intervention strategies, Arm 1 – Patient-only and Arm 2 - Patient +
Pharmacist compared to Arm 3 – Usual Care within a large, integrated care delivery system (Kaiser
Permanente Northern California). This 3-arm design allows us to examine the impact of two versions of
CGM-based program implementation that require different levels of health system investment (i.e.,
patient-education and training with or without added clinical personnel). AIM 2: We will also examine
heterogeneity of intervention treatment effects by clinical context (baseline glycemic control, concurrent
comorbidity) and patient context (age, health literacy) to inform future adaptation and dissemination
strategies. This safety-oriented intervention strategy incorporating alarm-enabled CGM provides the
potential for a low-burden approach to helping high-risk patients reduce incidence of severe
hypoglycemia. If successful, the RCT evidence from this study will support new models of care
designed to improve patient safety and patient-centered outcomes for older adults with T2D.

Public health relevance
Project Narrative Older adults with type 2 diabetes are at higher risk for severe hypoglycemia and its related complications (including hospitalization and death) when taking insulin. We propose to evaluate, in a randomized clinical trial, a strategy of safe insulin prescribing based on an educational program that uses continuous glucose monitoring to support older adults at high risk for hypoglycemia. If the aims of this project are achieved, this novel care strategy could be widely applied to reduce severe hypoglycemia episodes in older, high-risk adults with type 2 diabetes.